Research Training in Rheumatology

Project Summary
The primary goal of this T32 program is to provide outstanding research training in the pathogenesis of
rheumatic and autoimmune diseases for individuals at several key levels of career development (medical
student, predoctoral graduate student and postdoctoral MD and PhD fellow). The longstanding scientific
opportunities in Denver in basic, translational and clinical research, as well as health services and outcomes
research, provide a highly supportive environment to promote the broad goals of this training program. Newly
developed programs have increased the emphasis on studying diseases more prevalent in under-represented
minority populations as well as recruiting members of these groups into academic pathways. These efforts join
together with longstanding innovation programs available through the NIH-funded Colorado Clinical and
Translational Sciences Institute (CCTSI), with its Clinical Research Training Program and formal didactic
training in clinical investigation for MD and PhD trainees, to increase opportunities and positively affect our T32
program. In addition, >20 Graduate School PhD programs provide substantial formal training as well as
intellectual and laboratory resources for trainees interested in basic research. Extensive mentoring and
educational programs in responsible conduct of research and scientific rigor continue to enhance the quality of
the training experiences. Additionally, the ongoing support of the NIH-funded Autoimmunity Prevention Center,
the Studies of the Etiology of Rheumatoid Arthritis (SERA), a rapidly expanding Colorado Center for
Personalized Medicine, newly established programs in spondyloarthritis pathogenesis and prevention, and the
Colorado School of Public Health further facilitate a comprehensive training environment. The training program
will remain for this competing renewal under the direction of Dr. Michael Holers, Professor of Medicine and
Immunology and Head of the Division of Rheumatology. Dr. Holers will work closely with an Executive
Committee and Co-Director Dr. Kristi Kuhn. Thirty Participating Faculty Members will contribute. Notably,
based on opportunities through development of a new Pediatric Rheumatology training program by Dr. Rob
Fuhlbrigge and two years of successful research productivity by one of those fellows funded through an
INCLUDE Down Syndrome T32 supplement, support is requested to expand from three to four postdoctoral
fellows per year. Continued support for two medical students and two pre-doctoral graduate students per year
is requested. The curriculum for the School and Department of Medicine includes research-intensive programs
that provide access to highly motivated medical student short term trainees as well as individuals participating
in the Medical Scientist and Physician Scientist Training Programs. The primary criteria by which the program
will continue to be judged is the successful development of academic investigators who drive basic and clinical
research advances necessary to improve the health of patients with rheumatic and autoimmune diseases.
Leadership of this T32 hope to have the opportunity to continue support for their trainees.

Public health relevance
Project Narrative Through intensive mentoring in a highly interactive and collaborative research environment, this T32 program will support the development of outstanding MD, MD/PhD and PhD investigators whose research focus is on rheumatic and autoimmune disease pathogenesis, prevention and treatment. This program has demonstrated substantial success in supporting predoctoral trainees and postdoctoral fellows who are currently in academic positions or evolving academic tracks. Based on positive outcomes in the current funding cycle, we propose to continue to include trainees at both of these key earlier career development periods, as well as short term medical students who are highly motivated to develop research skills and insights into disease.